The Development and Consequences of the Stereotype that Girls Must Work Harder than Boys to Succeed in Math

PROJECT SUMMARY
Whereas men's intellectual successes are often described as resulting from intrinsic talent, women's
intellectual successes are more often credited to their dedicated efforts (Swim & Sanna, 1996). These gender-
stereotyped attributions of success are particularly pronounced when evaluating others' achievements in male-
dominated science, technology, engineering, and math (STEM) fields. That is, whereas men's scientific
accomplishments are often ascribed to natural talents, women's similar successes are more often attributed to
their dedication. Children's math achievements are also subject to these stereotype-driven evaluations: both
parents and teachers reporting that girls must put forth more effort than boys to attain the same level of math
proficiency by first grade (e.g., Frome & Eccles, 1998; Robinson-Cimpian et al., 2014). These findings align
with evidence that women believe they must exert greater effort than their peers to achieve similar levels of
success in male-dominated disciplines, a belief that diminishes women's educational pursuits in STEM fields
(Smith et al., 2013). Thus, attributing girls' math achievements to their efforts may reduce girls' learning
outcomes in math-related domains, ultimately constraining their educational and professional aspirations from
an early age. To address this possibility, the proposed research will examine the development of gender-
stereotyped achievement attributions and their relation to girls' attitudes and motivation toward novel math
activities. The goal of this research is to contribute insight into early-emerging psychological processes that
impede girls' learning in math.
The proposed research will be the first to investigate the origins of gender-stereotyped attributions of success
during childhood and characterize their relations to girls' attitudes towards math-related educational activities.
This research will consist of three studies. Study 1 will examine the extent to which children differentially
attribute the academic success of females and males throughout childhood. Study 2 will assess whether girls
expect to devote greater effort than boys to succeeding in math activities, and if so, whether greater effort
expectations reduce girls' motivation to engage in such activities. Study 3 will test whether emphasizing that
effort, rather than ability, is critical to success of all children will increase girls' interests and confidence in
pursuing novel math activities. Together, these studies will (1) offer insight into the development of gender-
stereotyped achievement attributions and (2) provide a theoretically plausible and practically significant
framework from which to develop interventions aimed at enhancing girls' math learning outcomes.

Public health relevance
PROJECT NARRATIVE The objectives of this research are (1) to document the development of gender stereotypes regarding the origins of women's and men's intellectual achievements and (2) to understand the consequences of these stereotypes on social and motivational processes that relate to children's math learning. The ultimate goal is to develop a theoretically plausible and practically significant framework from which to design educational tools that enhance girls' math learning outcomes.